Admin Core

ACE Administrative Core; PI: Pascual, Virginia
Project Summary – Administrative Core
The Administrative Core provides an important facilitative resource to Weill Cornell Medicine’s Autoimmunity
Center of Excellence (ACE) entitled, ‘Immune Cells and Secretory Pathways Leading to Human Systemic
Autoimmunity’. The proposed Center is comprised of a highly integrated multidisciplinary team of scientists,
physician scientists, computational biologists and other technical staff and involves a Principal Project, a
Collaborative Project, a Pilot Project and three Cores (Administrative, ACE Funds Management and ACE
Biorepository Core). Thus, there is considerable need to organize various activities and provide support in order
to facilitate a cohesive, efficient and productive ACE team at WCM. The Administrative Core will have a Director,
a Program Administrator and an Administrative. Objectives of this Core are to: 1) Facilitate communication,
provide organizational and scientific leadership and foster a strong collaborative environment within the
Center at Weill Cornell Medicine (WCM) and among other ACE sites; 2) Provide oversight and monitoring of
progress of Projects and Cores towards their specific milestones and support reporting requirements; 3)
Optimize resource allocation and fiscal management; 4) Seek guidance from the ACE Steering Committee and
NIH program officials, implementing their recommendations, and generating progress reports; 5) Oversee
regulatory, material transfer and data use agreements surrounding research using human subjects and 6)
Ensure rigorous data and sample management infrastructure and efficient data and resource sharing.
OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page